Functional Genomics Shared Resource

ABSTRACT
Overview: Functional genomics approaches are a central pillar of modern cancer research. By enabling the
manipulation of gene function and quantitative analysis of such perturbations, functional genomic tools contribute
to the elucidation of genotype-to-phenotype relationships controlling cancer development and response to
therapies. The field of functional genomics, a direct product of the Human Genome Project, has rapidly evolved
with the advent of technologies such as RNA interference (RNAi) and rapid genome editing (e.g. CRISPR), which
in turn facilitated the investigation of large numbers of genes in vertebrate cells in a single experiment. The
Functional Genomics Shared Resource (FGSR) provides UCCC members access to tools that investigate gene
function on a genome-wide scale; develops novel protocols and offers expertise for the use of functional
genomics tools; and provides a forum for scientific exchange. By promoting collaboration in functional genomics,
the FGSR serves to catalyze discoveries by UCCC members. Services: The FGSR provides reagents to
members in ready-to-use and cost-effective formats. Additionally, a variety of personalized services like custom
design and creation of shRNA and CRISPR panels targeting gene collections of interest, and cell engineering
are also offered. Reagents/Tools: Through continuous assessment of novel technologies and UCCC members'
needs, the FGSR has acquired genome-wide short hairpin RNA (shRNA), Open Reading Frame (ORF) and
CRISPR libraries. The FGSR's human and mouse shRNA collections contain 176,283 clones and 138,538
clones, respectively. The ORF library contains 15,744 plasmids for overexpression of 13,082 unique human
genes. The arrayed CRISPR library has 2 gRNAs per gene for 16,190 human genes. The FGSR also houses
genome-wide shRNA libraries, myriad of pathway-focused shRNA panels, gene knockout CRISPR libraries like
the GeCKO and Brunello and transactivating SAM libraries in ready-to-use format. Management: The FGSR is
managed by the UCCC, and is overseen by the Associate Director for Basic Research. Use: Since July 2016,
318 individuals from 146 investigator laboratories have used services. Fifty-nine percent of these teams (86)
were UCCC members, representing all four Programs and resulting in 80 peer-reviewed publications. Operating
Budget: CCSG funding represents 43% of the annual operating budget and the remaining support is from user
fees (30%) and institutional funds (27%). Consultation/Education: FGSR personnel assist members on a daily
basis with experimental design and troubleshooting. The FGSR collaborates with other SRs to create robust
protocols for seamless use of reagents across SRs. The website hosts a large number of very detailed protocols
and bibliographic sources that are updated constantly. The FGSR also hosts `technology forums' where UCCC
members are updated on the latest developments and applications in the field. Future Directions: The FGSR
will continue to acquire the latest tools in the functional genomics field, such as novel CRISPR-based
technologies. The service and education portfolio will be expanded via technology forums and webinars.